An Oral (Gavage) Two-Generation Reproductive Toxicity Study of Eugenol in Rats (StudyNo. 01567001)

An Oral (Gavage) Two-Generation Reproductive Toxicity Study of Eugenol in Rats (Study No.
01567001)
Project Summary
To evaluate the potential adverse effects of the test article on reproduction in a two-generation study.
This will include determining the effects of the test article on male and female reproductive processes
including gonadal function, estrous cyclicity, mating behavior, conception, gestation, parturition,
lactation, weaning and on growth and development of the offspring. A minimum of one litter will be
produced in each generation. In addition, the toxicokinetics of the test article will be examined during
the study.

Public health relevance
An Oral (Gavage) Two-Generation Reproductive Toxicity Study of Eugenol in Rats (Study No. 01567001) Project Narrative The design of this study was based on the study objective(s), the overall product development strategy for the test article, and the following study design guidelines: • United States Food and Drug Administration’s (FDA) Redbook 2000 Guidelines for Reproduction Studies (Toxicological Principles for the Safety of Food Ingredients, as updated). • United States Food and Drug Administration’s (FDA) Center for Veterinary Medicine, Safety studies for Veterinary Drug Residues in Human Food: Reproduction Toxicity Testing (VICH GL22), July 2006. • OECD Guideline 417. Toxicokinetics.